Institutional Training Program in Nutrition

PROJECT SUMMARY
This application seeks renewal of a long-standing, innovative and highly successful postdoctoral training
program in Nutrition that has a primary goal of training the next generation of physician scientists and PhD
researchers committed to disease prevention and health promotion through careers in Nutrition. As
suboptimal diets have surpassed tobacco smoking as the leading global mortality risk factor, the rationale
for an outstanding nutrition research workforce is compelling. The training program, based in a major
academic medical center, addresses 3 broad themes: 1) obesity and its co-morbidities; 2) nutrition, diet and
eating behavior; and 3) lifecourse and development. Faculty mentors include a balanced mix of MD (10)
and PhD (14) researchers representing 5 academic units in the university, and whose nationally recognized
research spans basic (T1) to translational (T4) approaches. All faculty are affiliated with the NIH-supported
Colorado Clinical and Translational Sciences Institute, which offers excellent support for translational
research and numerous training and career development programs. Trainees to date typically have been
physicians (1 position) seeking a career in academic medicine and nutrition-related research and PhD’s (2
positions) pursuing postdoctoral training in one of our thematic areas. The specific objectives of the training
program include achieving excellence in all aspects of the scientific literature and methods relevant to
trainees’ areas of research, with an emphasis on understanding scientific rigor and reproducibility and
guiding principles of ethical conduct in research; mastering basic principles of Nutrition Science; preparing
and submitting research grants and manuscripts; and acquiring skills for professional development and
communication to undertake a successful academic career. The program provides 2-3 yr of research
training, which includes ongoing rigorous work with a primary mentor, and interaction with faculty leadership
and all trainees supported by this T32 plus other pre- and postdoctoral trainees through participation in
weekly Nutrition Journal Club, professional development series and Nutrition seminar series. Of recent past
trainees, two-thirds have obtained grant funding, and 80% have progressed to careers in academic settings.
Based on increases in the quality and number of applicants, including physicians, relative to number of
available slots, we propose an additional position for the next cycle, thus projecting 2 MD and 2 PhD
trainees. The training environment promotes collaborative research and fosters productive interaction
between physicians and PhD researchers, a model that prepares trainees to be exceptionally well
positioned to emerge as future leaders in Nutrition to address the most compelling global health challenges.

Public health relevance
NARRATIVE The research training provided by this program, based in an academic medical center, will accelerate the development of the next generation of physician-scientists and PhD researchers in the field of Nutrition. Research areas include obesity and its health effects, nutrition and eating behavior, and the effects of nutrition over entire lifespan, and the approaches span from bench to bedside to community-based research. All fellows will be poised to launch successful independent research careers in translational Nutrition science and to be leaders in disease prevention and health promotion.